Spatially Structured Synthetic Consortia of Microbes to Understand and Engineer Cells in 3D Environments

Project Summary/Abstract
Microbes in natural habitats mostly exist in groups arranged in the 3D space of biofilms, and spatial
heterogeneity plays a key role in the stabilization, communication, and functions in these multi-species
consortiums. However, a proper platform to build a synthetic community of bacteria and systematically vary the
spatial parameter to deduce key fundamental knowledge in 3D microbial consortia – cellular phenotype,
differentiation, communication, gene expression, and metabolism – is currently lacking. My research program
aims to (1) develop a printing platform to construct 3D microbial consortia with well-defined polymers, (2) study
the physiology of cells confined in these 3D environments, and (3) engineer cells and their 3D arrangement to
yield biomaterials performing useful functions. The outcomes of our research endeavor will be (1) new
fundamental knowledge and understanding of microbial consortia with a 3-dimensional spatial context and (2)
functional biomaterials directly contributing to human health. Our contributions will be significant and have a
long-lasting impact by filling in the critical knowledge gap in our understanding and engineering capability of
microbial consortia relevant to biomedical science.

Public health relevance
Project Narrative Despite that majority of microbes found in nature exist and function in spatially organized communities, our current basic understanding of microbes is heavily based on the studies performed in liquid cultures. Therefore, the next frontier is to understand the group behavior and physiology of microbes with a pre-defined spatial context and engineer synthetic consortia in a well-defined 3D framework for desired functional outcomes. The proposed research is relevant to public health because expanding our fundamental understanding of naturally- occurring communities of microbes will enable us to better control/treat clinically relevant biofilms and engineer biomaterials useful for human health.